An Innovative Immune Therapy Targeting the TREM1-Inflammation Pathway to Alleviate Excess Inflammation in Ulcerative Colitis of Geriatric Patients

Abstract
One million Americans live with Ulcerative Colitis (UC), and 30% of that population is over 60. Thirty-eight
thousand new cases are diagnosed yearly, with 15% over 65. More than a quarter of UC patients are aged,
and prevalence in the over 65 is increasing at an annual rate of 2.8%. Surgery treatment is risky in geriatric
patients, and better therapy is needed. UC is an immune-mediated disorder of the colon that is debilitating and
not medically curable. Extensive studies have shown a pathogenesis due to aberrant immune responses to the
intestinal microbiota, resulting in acute and chronic inflammations characterized by infiltrates of activated
macrophages (MΦ), neutrophils (Ns), and lymphocytes, indicating a deregulated activation of the intestine-
innate immunity responder cells (MΦ and Ns). In UC, correlating with this deregulation is the unusual
expression of the Triggering Receptor Expressed on Myeloid cells-1 (TREM1) on the intestinal MΦ and the
presence of activated platelets expressing a ligand for TREM1. TREM1 is a potent activation receptor of MΦ
and Ns, and its excess triggering leads to the overproduction of inflammatory mediators and excess
inflammation. Two-thirds of patients obtain only partial or no benefit from current therapies, specifically those
with MΦ high-TREM1 expression sustained inflammation. Over 1400 scientific articles document the role of the
TREM1-activation pathway (TAP) in inflammation. We have identified TREM1-sv, a natural splice variant and
competitive inhibitor of TREM1, which can downregulate TAP. TREM1-sv was very efficient at downregulating
excess inflammation in preclinical sepsis trials, a disease driven by a deregulated TAP. In UC, deregulation of
TAP might occur from depletion of TREM1-sv, ensuing persistent activation of myeloid cells from activated
platelets. We anticipate that administering TREM1-sv intravenously or subcutaneously will stop the excess
inflammation. The rationale is that TREM1-sv downregulates TAP by competing for the TREM1 ligands,
thereby reducing the number of TREM1-ligand complexes and avoiding an excess triggering activation of MΦ
and Ns. Hence, the intestine can recover a healthy immunity and heal. We aim to show therapeutic efficacy by
conducting experiments in which different regimens of TREM1-sv are administered to well-established mouse
models of chronic ulcerative colitis with altered innate immunity. We use a custom-made strain of P. pastoris to
produce a batch of purified biologically active human recombinant (hu r) TREM1-sv for animal treatments. After
induction of UC, inflammation will be assessed before and after hu rTREM1-sv treatment with an established
four-parameter UC scoring system and correlated with measurements in the blood of the inflammatory cytokine
levels and TREM1-sv concentration. Neutralization experiments with an anti-TREM1-sv antibody and
comparative anti-TNF therapy will be conducted. We aim to produce innovative data demonstrating the benefit
of hu rTREM1-sv to downregulate hyperactive intestinal inflammation in UC. Downregulating TAP with hu
rTREM1-sv is an innovative scientific approach to alleviate excess inflammation in UC patients.

Public health relevance
Project Narrative One million Americans live with Ulcerative Colitis (UC), a debilitating disease presently not medically curable. More than a quarter of UC patients are aged, and prevalence in the over 65 is increasing at an annual rate of 2.8%. UC is an immune-mediated colon disorder driven by an excess inflammation from an overactivated primary-immune response. We have identified BioTremvarTM, a natural blood constituent regulating the primary immune response that has shown solid efficacy in inhibiting deadly excess inflammation in another disease with a deregulation of the primary immune response. We aim to evaluate its therapeutic effectiveness in treating UC. BioTremvarTM therapy is anticipated to alleviate UC excess inflammation and symptoms, allowing recovery to clinical-free symptoms for thousands of afflicted people.